Intracellular trafficking of the essential signaling metabolite heme in myeloid cells: impact on physiology and disease

The growth factors and transcriptional activators that give rise to diverse populations of functionally distinct
circulating monocytes and tissue-resident macrophages (MFs) have largely been identified. In contrast, the
influence of metabolic signals from the local tissue microenvironment on MF differentiation and function remains
essentially unexplored. One endogenous signal that been associated to MF differentiation in homeostatic
conditions is the essential metabolite heme, the body’s main purveyor of iron, which directs red pulp MF (RPM)
differentiation. As RPMs degrade senescent red blood cells, they accrue large amounts of hemoglobin-derived
heme. This buildup of intracellular heme triggers degradation of the heme-regulated transcriptional repressor
BACH1, thus inducing expression of SPIC1, a transcription factor (TF) required for RPM development. Beyond
its role in regulating RPM differentiation, our preliminary data show that BACH1 plays a previously unappreciated
outsized role in myeloid cells. We find that BACH1 is part of the small set of core factors that regulate MF identity
and function, and that it integrates the transcriptional response to signaling heme and pro-inflammatory stimuli.
Supporting this notion, mice lacking BACH1 in myeloid cells have altered numbers of tissue-resident MFs, and
cells derived from them show reduced fitness in bone marrow transplant repopulation studies. Moreover, myeloid
BACH 1 KO mice have alterations in the inflammatory/repair process in the setting of acute muscle injury, and,
unlike WT littermates, quickly perish when given with a sublethal dose of LPS. Given that BACH1 activity is
regulated by heme, these unexpected findings stress the extent to which heme signaling regulates MF biology
and highlight the need to gain insight into the pathways of intracellular heme delivery that control BACH1 function.
Heme is a vital metabolite for life, but due to its highly oxidative iron content, free heme is very cytotoxic. As
such, heme intracellular mobilization requires a protein network to enable its transfer throughout the cell, the
components of which are largely unknown. We have discovered in adipocytes an intracellular heme trafficking
pathway mediated by the poorly characterized proteins Progesterone Receptor Component 1 and 2 (PGRMC1,
PGRMC2), that delivers heme to proteins in the ER and the nucleus, including heme-responsive TFs such as
BACH1. We recently found that the PGRMC1/2 heme trafficking pathway is active in MFs, and that PGRMC1/2
DKO MFs have increased BACH1 levels and functional defects. Our hypothesis is that in monocytes/MFs, the
PGRMC1/2 pathway is central for delivery of heme to the nucleus, and that BACH1 is a principal mediator of the
effects of heme signaling on MF differentiation and function under normal and pathological conditions. In this
project, we leverage unique mouse models with reduced nuclear heme, chemical tools that increase signaling
heme flux to the nucleus, and new mouse mutants of the key mediator BACH1 to reveal a molecular pathway
for metabolite control of MF differentiation/function.

Public health relevance
The growth factors and transcriptional activators that specify monocyte/macrophage (MF) differentiation into diverse types of monocytes and tissue-resident MFs have largely been identified. In contrast, the impact of environmental signals – particularly that of endogenous metabolites – on MF differentiation and function remains essentially unexplored. In this project we will characterize the impact of intracellular trafficking of heme, a vital metabolite, in MF biology and its role in homeostasis and disease.